Reprogramming of cardiac genome by Smyd1 in hypertrophy and failure

PROJECT SUMMARY/ABSTRACT It is now appreciated that genomes are dynamic and that selective packing of DNA governs the expression of distinct sets of genes in a cell. The wrapping of DNA around nucleosomes and its organization into higher order structures is fundamentally influenced by chromatin remodeling enzymes. These enzymes selectively position nucleosomes along the DNA strand and influence the interaction of histones with DNA by modifying the amino terminal tails of histones. Gross changes in chromatin structure are most prominent during development and influence cell fate by establishing cell-type-specific gene expression. Changes in chromatin structure have also been observed during disease and disruption of chromatin remodeling enzymes has been implicated in cardiac hypertrophy. However, a clear picture of the protein networks that modulate chromatin architecture in the heart is needed to understand how gene expression is reprogrammed on a genome-wide scale during disease. Although the post-translational modification (PTM) of histones has been well established, the enzymes responsible for the selective addition and removal of these regulatory marks have only begun to be characterized. A newly emerging family of histone methyltransferases (HMTs) is called Smyd. Germline deletion of the muscle-restricted family member, Smyd1, leads to embryonic lethality due to impaired cardiac differentiation. Consistent with this observation, overexpression of Smyd1 in muscle precursor cells led to accelerated differentiation. Despite these intriguing insights into the role of Smyd1 during development, its endogenous localization, regulation and role in cardiac disease are unknown. My preliminary data demonstrate increased Smyd1 abundance during heart failure and establish the approaches to determine its activity, intracellular localization and mechanisms of action in this application. The short term goal of this application is to understand the role of Smyd1 in the adult myocardium and to characterize its downstream targets during heart failure. The long term goal of this project is to integrate these concepts to understand the factors that confer targeting specificity to Smyd1 in the cardiac genome. This application leverages state-of-the-art proteomics, animal physiology, biochemistry, imaging and next generation sequencing technology to advance our understanding of heart failure. Our approach will provide fundamental insights into the activation and regulation of HMTs, as well as the mechanisms that confer specificity in their targeting of the genome. The significance to the clinical realm is to provide a mechanistic basis for how the genome is reprogrammed with disease, such that future interventions can target specific chromatin remodeling events therapeutically.

Public health relevance
PROJECT NARRATIVE Heart disease is the leading cause of death in the developed world. The goal of this grant is to understand how a specific protein called Smyd1 modulates the expression of genes in the normal heart and how changes in its function during disease affect the development of cardiac hypertrophy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS It is now appreciated that genomes are dynamic and that selective packaging of DNA governs the expression of distinct sets of genes throughout the life of a cell. The wrapping of DNA around nucleosomes and its organization into higher order structures is fundamentally influenced by chromatin remodeling enzymes.1 These enzymes selectively position nucleosomes along the DNA strand and influence the interaction of histones with DNA by modifying the amino terminal tails of histones.2 Gross changes in chromatin structure are most prominent during development and influence cell fate by establishing cell-type-specific gene expression.3 Changes in chromatin structure have also been observed during disease and disruption of chromatin remodeling enzymes has been implicated in cardiac hypertrophy.4, 5 However, a clear picture of the protein networks that modulate chromatin architecture in the heart is needed to understand how gene expression is reprogrammed on a genome-wide scale during disease. To address this, I carried out an exhaustive analysis of cardiac chromatin during the development of pressure overload hypertrophy following transverse aortic constriction (TAC) in the mouse. These studies focused my attention on changes in a histone methyltransferase called Smyd1, which I found to be up- regulated at the protein level following TAC. Although the post-translational modification (PTM) of histones has been well established, the enzymes responsible for the selective addition and removal of these regulatory marks have only begun to be characterized. Germline deletion of smyd1 established its necessary role to promote myocyte differentiation and cardiac development.6 Furthermore, Smyd1 mRNA levels were up- regulated in explanted failing human hearts (which exhibit characteristics of de-differentiation).7 My collaborator Phil Tucker observed that cardiac-restricted loss of smyd1 from birth induced hypertrophy (Fig 11). Despite these intriguing preliminary studies, the mechanisms for Smyd1's intracellular localization, endogenous activity and genomic targeting are completely unknown. I hypothesize that Smyd1 regulates gene expression through histone methylation to establish and maintain the differentiated state of the cardiomyocyte. During hypertrophy Smyd1 is up-regulated as an endogenous compensatory mechanism to mitigate disease-induced cardiac remodeling (Fig 1). To address this hypothesis I propose the following aims (please see Budget Justification for Timeline): Aim 1: To discover and validate nuclear proteins that regulate the genome during cardiac hypertrophy and failure: focus on Smyd1. I have determined changes in abundance and modification of nuclear proteins during the development of cardiac hypertrophy in mice. I will exhaustively characterize changes in one of these proteins, Smyd1, in a cell model of hypertrophy. I will determine changes in the downstream target of Smyd1, histone H3, in vivo using western blotting and microscopy to measure K4 methylation. Aim 2: To elucidate mechanisms regulating Smyd1 abundance, activity and nuclear localization. I will determine the binding partners of Smyd1 in the heart using co-immunoprecipitation and mass spectrometry, and will determine the effect of hypertrophic stimuli on this interactome. I will determine what effect one of these regulators, HSP90, has on its enzymatic activity and will investigate abundance and intracellular localization of Smyd1 in the normal and diseased heart. Aim 3: To determine the effect of gain or loss of Smyd1 function on the phenotype of the adult myocardium. I will generate inducible cardiac-specific Smyd1 KO (α-MHC-MerCreMer/Smyd1flox/flox mice) mice by crossing floxed-Smyd1 mice with transgenic mice expressing a Cre-estrogen receptor fusion under control of the α-MHC promoter.8 I will also create inducible cardiac-specific Smyd1 overexpressing mice. I will determine how gain or loss of Smyd1 function in the adult heart affects morphology, cardiac performance and gene expression under basal conditions and after TAC. Aim 4: To determine the mechanisms by which Smyd1 regulates the cardiac genome during hypertrophy. I will use microarrays to determine transcripts differentially regulated in the hearts of tamoxifen- treated α-MHC-MerCreMer/Smyd1flox/flox mice as compared to untreated controls and in the presence and absence of hypertrophic stimuli. I will identify sites of Smyd1 binding by performing genome-wide Smyd1 Chip-Seq. I will explore the mechanisms which confer the nucleosome specificity of Smyd1, specifically evaluating the role of regulator proteins, histone PTM's, and primary DNA sequence.